New anti-tubercular agents targeting intracellular bacteria

Summary
Tuberculosis remains a major global health burden with ~1.6 million deaths in 2021 and a latently-infected
population of billions. Mycobacterium tuberculosis, the causative agent, is a sophisticated pathogen which can
persist for decades in the human host and which requires lengthy treatment for cure with multiple antibiotics.
One of the features of M. tuberculosis is its ability to survive and replicate inside human cells, including
macrophages, one of the normal host defense mechanisms against infection. Intracellular bacteria are a specific
population which can be hard to kill, in part due to the requirement that molecules enter eukaryotic cells, and in
part due to the different physiological state in which the bacteria persist. Increasing evidence points to a higher
level of antibiotic tolerance in intracellular bacteria, as well as increased heterogeneity.
In order to identify new drugs which can shorten therapy, we focused on the identification of novel anti-tubercular
agents which are active against intracellular bacteria. We identified a number of scaffolds which inhibit
mycobacterial intracellular replication using a high content screen to monitor bacterial and eukaryotic cell survival
simultaneously. From these, we selected high priority series with attractive properties for further evaluation.
The overall aims of this proposal are to (i) evaluate a high priority chemical series with intracellular activity, (ii)
identify the target and mechanism of action of this novel series and (iii) determine the best companion agents
for a new regimen. The major outcome will be a molecule series with a known mechanism of action with in vivo
validation ready for lead optimization.

Public health relevance
Narrative Mycobacterium tuberculosis is the causative agent of human tuberculosis, a devastating infectious disease, which infects millions of people and kills ~1.5 million annually. M. tuberculosis can replicate inside macrophages, where it becomes antibiotic tolerant and harder to kill. The aim of this proposal is to identify new anti-tubercular agents which target intracellular bacteria and to determine the mode of action of these agents.